Evaluating timing and extent of prenatal exposure to dolutegravir and early childhood outcomes

Despite strides in preventing vertical HIV transmission globally, 150,000 infants still acquired HIV in 2019. New
antiretroviral therapy (ART) regimens containing dolutegravir (DTG) achieve rapid viral suppression in pregnant
women living with HIV (WLHIV), which could facilitate elimination of vertical HIV transmission. The WHO
recommends DTG for first-line ART in all populations, including pregnant WLHIV. In Kenya, rollout of DTG as
first-line ART for pregnant WLHIV began in 2018. Safety data on prenatal DTG use are reassuring, yet studies
to date have <1 year of follow-up and do not quantify DTG exposure. Evaluations of longer-term outcomes with
measured DTG exposure are required. Assessing longer-term neurodevelopmental outcomes following ARV
exposure also remains crucial. HIV-exposure in-utero may compromise HIV-exposed uninfected (HEU)
children’s neurodevelopment due to maternal immune activation affecting the developing fetal brain. Neurologic
damage caused by HIV exposure in utero could be reversed by ART. Yet, ART exposure may impact HEU infant
neuro-related outcomes due to ART-related toxicity. To date, no studies compare neurodevelopment outcomes
between HEU children with both HIV and ARV exposure and HIV-unexposed uninfected (HUU) children with
only ARV exposure. We are conducting a safety evaluation (n=1300) in Kenya of infant PrEP exposure with
neurodevelopmental assessment (R01HD100201, PrIMA-X). We propose using data from our ongoing PrEP
safety evaluation and building a new cohort of HEU infants with DTG-ART exposure to evaluate if birth, growth,
or neurodevelopment outcomes differ for HEU infants with both HIV and ARV exposure, HUU with only ARV
exposure, and HUU with neither HIV nor ARV exposure. For Aim 1, we will establish a new cohort of pregnant
WLHIV who initiate DTG at specific timepoints—pre-conception; 1st and 2nd trimester—and collect hair samples
from WLHIV in pregnancy (monthly), and from mother-infant pairs at delivery, and along with breastmilk samples
postpartum (6wks, 14wks; 6mos, 9mos) to assess cumulative DTG exposure. We will quantify DTG levels using
validated assays and assess infant-to-maternal ratios of hair DTG levels (representing degree of transfer). Aim
2 will focus on evaluating infant outcomes (preterm delivery <37 weeks gestation, small for gestational age <10th
percentile, stillbirth, neonatal death, growth) following DTG exposure during pregnancy/breastfeeding and will
determine whether timing of DTG initiation or extent of DTG exposure are associated adverse birth/infant
outcomes among pregnancies exposed to DTG and HIV. Aim 3 will additionally utilize data from our ongoing
PrIMA-X study to evaluate whether perinatal, growth, and neurodevelopmental outcomes up to 36 months differ
between HEU infants with ARV exposure (DTG-ART), HUU infants with only ARV exposure (PrEP), and HUU
infants with neither HIV nor ARV exposure. This Project synergizes with the other P01 Projects which examine
alternate biologic factors that may influence HEU outcomes. Project 1 will also provide a maternal/infant sample
repository (hair, dried blood spots, and breastmilk) for future studies.